Training Grant in Diabetes and Endocrinology

The purpose of this training program is to nurture the next generation of leaders in diabetes,
metabolism, and endocrinology research by providing post-doctoral candidates of exceptional
promise with the opportunity to train for successful careers in academic endocrinology. The
program is limited to post-doctoral applicants who hold MD and/or PhD degrees and have
demonstrated a strong interest in or prior exposure to biomedical research. Key program
features include intensive research in the laboratory and programs of participating faculty
members and broad didactic exposure to basic science, translational and clinical investigation.
Research areas span a wide range of endocrine disciplines, including diabetes, energy
homeostasis and weight control, lipid and lipoprotein metabolism, neuroendocrinology,
metabolic bone diseases, genetic foundation of endocrine diseases, and enteroendocrine cell
pathophysiology. Scientific methods employed by the faculty span the gamut from early
discovery using model organisms, biochemical, biophysical, and systems biology approaches,
clinical hypothesis-testing, early validation of new treatment modalities, clinical trials, and public
health outcomes of commonly employed standards of care. By virtue of the breadth of expertise
of the participating faculty, trainees can select research questions that leverage their own
interest and enthusiasm to best suit their career goals. Training faculty and facilities are
predominantly in the Division of Endocrinology of the Department of Medicine at the Vagelos
College of Physicians & Surgeons of Columbia University. However, the program is
distinguished by its broad reach into different areas of medical practice, as well as scientific
homes in Departments of Genetics, Physiology and Cellular Biophysics, Pathology and Cell
Biology, and Pharmacology. Trainees are selected from a competitive applicant pool after
thorough vetting of their credentials by the Recruitment and Admissions Committee, with
significant involvement of the Diversity Enhancement Committee. Applicants admitted to the
program are carefully mentored by Research and Mentorship as well as Career Development
Committees, which form the basis of individual trainee committees. Post-training, the proposed
training program provides continued mentoring and advice on the transition to faculty positions
to foster independent academic careers in diabetes, metabolism, and endocrinology.

Public health relevance
The Training Grant in Diabetes, Metabolism, and Endocrinology at the Vagelos College of Physicians & Surgeons, Columbia University, provides training in basic, translational, and clinical research to individuals with a background in biomedical research, holding MD and/or PhD degrees. The program aims to leverage the considerable human, scientific, and clinical resources of Columbia University to help trainees achieve academic distinction, establish themselves as leading investigators, and improve the practice of medicine.